Development Core

DEVELOPMENT CORE: PROJECT SUMMARY
The goal of the Development Core is to advance innovative, high-impact population science. It does so
through: 1. mentoring and investing in the research and success of early career scholars; 2. promoting and
nurturing new population science and the funding success of PSTC Associates; and 3. providing opportunities
for interdisciplinary intellectual exchange through seminars, workshops, and trainings.